Evaluating the Impact of ACEs Screening and Behavioral-Social Support on Obstructive Lung Disease Health Outcomes

ABSTRACT
The health and economic impacts of asthma and chronic obstructive pulmonary disease (COPD) in the United
States are substantial and disproportionally burden marginalized and economically disadvantaged populations.
Despite the existence of well-established guidelines for the treatment of asthma and COPD and preventative
service recommendations, these glaring disparities highlight the need to better understand the upstream risk
factors and psychosocial barriers associated with poor outcomes. One emerging risk factor is exposure to
adverse childhood experiences (ACEs), which are stressful or traumatic experiences in childhood that are
thought to have a long-term health effects. The association between ACEs and asthma prevalence in children
and adults is well-established and there is evidence for a similar association with COPD in adults. In 2020, the
Los Angeles Department of Health Services (LADHS) implemented ACEs screening, becoming one of the
earliest and largest health system to adopt the practice across the state of California. With over 28,000 patients
screened for ACEs, there is a unique opportunity to answer a critical gap in understanding the mechanism of
action through which ACEs impact COPD and asthma. Exposure to ACEs creates complex social conditions
which operate as risk factors for disease as well as interfere with an individual’s ability to access and adhere to
guideline-concordant care and other preventative services. The fundamental aim of this proposal is to leverage
data from the implementation of ACEs screening in LADHS to examine short- and long-term asthma and COPD-
related health outcomes. Specifically, this proposal will 1) Examine the association between ACEs and asthma
and COPD prevalence and morbidity in a racially and ethnically diverse population of children and adults 2)
Examine the associations between ACEs and the delivery of guideline concordant care and preventative services
for children and adults with asthma and COPD, with a particular focus on examining disparities based on race
and language concordance, and 3) Evaluate the longitudinal impact of ACEs screening and linkage to socio-
behavioral resources on healthcare utilization and delivery of guideline concordant care for patients with asthma
and COPD. With 35,070 adult and pediatric ACEs initial and follow up screening encounters throughout LADHS,
linked medical record data, chronic disease registries, closed-looped socio-behavioral referrals, medication
prescription and filling data, and emergency services utilization records, the proposed study is well positioned to
fill a critical gap in understanding the long-term impact of screening and addressing childhood adversities on
asthma and COPD health outcomes. The results of which have the potential to change clinical practice and the
allocation of resources within health systems to address disparities in respiratory health. Furthermore, this award
will provide Dr. Adali Martinez with the necessary support to become an expert in implementation science and
health disparities with a focus on addressing social and structural barriers to facilitate access to guideline
concordant care and preventative services among those with chronic lung disease.

Public health relevance
PROJECT NARRATIVE As a measure of stressful or traumatic experiences in childhood, adverse childhood experiences (ACEs) have been associated with a high prevalence of multiple chronic conditions throughout the lifespan, including asthma and chronic obstructive pulmonary disease (COPD). Understanding the mechanisms by which ACEs impact obstructive lung disease will further inform the development of interventions to address these complex socio- behavioral factors. Additionally, evaluating the short- and long-term impact that screening for and intervening on childhood adversities has on respiratory health outcomes may inform further integration of ACEs screening and allocation of resources throughout health systems.